Metabolic pathways regulate metaplasia and cancer initiation in the pancreas

PROJECT SUMMARY
Activating mutations in KRAS reprogram cell metabolism to support growth, proliferation, and
survival in pancreatic cancer. However, there is little information on how KRAS-dependent
alterations in metabolism contribute to premalignant states and cancer initiation. Acinar-to-
ductal metaplasia (ADM) is a precancerous state essential in pancreatic ductal
adenocarcinoma. During ADM, acinar cells transdifferentiate to become more duct-like and
proliferative, usually in response to tissue damage. ADM is reversible but activating mutations in
KRAS lead to persistent ADM and progression to neoplasia and cancer. Recent studies also
show that healthy acinar cells can restrict and eliminate oncogenic KRAS-expressing cells.
Based on preliminary data, I hypothesize that healthy acinar cells alter their metabolism during
ADM to aid in redox homeostasis and restrict the growth of nearby oncogenic cells, thereby
restricting cancer initiation. Preliminary experiments show that Glucose-6-phosphate
dehydrogenase (G6pd) and Malic enzyme 1 (Me1) transcripts are significantly upregulated
during ADM. G6PD is the rate limiting enzyme in the pentose phosphate pathway and ME1
converts malate to pyruvate, linking glycolytic and citric acid cycles. In addition, both G6PD and
ME1 enzymes produce NADPH, which protects against redox stress. Aim 1 will focus on G6pd
and Me1 and determine how redox balance and NADPH production contribute to ADM
formation. Preliminary experiments show that loss of these enzymes increased the level of
reactive oxygen species in acinar cells. The experiments proposed in Aim 1 use genetically
engineered mouse models of pancreatic cancer, steady-state metabolomics, isotope tracing,
and ex vivo primary acinar cell culture to examine the consequence on ADM and tumorigenesis
when G6pd and Me1 are lost, and NADPH pools are reduced. Aim 2 will determine how
metabolic redox interactions between healthy and oncogenic cells restrict ADM. Preliminary
experiments suggest that healthy acinar cells secrete metabolites to inhibit adjacent KRAS-
expressing cells from undergoing ADM. This aim uses inducible mouse models of KRAS-driven
pancreatic cancer, metabolomics, and spatial transcriptomics. The proposed experiments will
help to identify how healthy cells sense the presence of neighboring oncogenic cells and
reprogram their cell state and metabolism to repress cancer initiation. Together, the aims
presented in this proposal will provide new mechanistic insights on how metabolic pathways
drive pancreatic cancer initiation, thereby informing future therapeutics.

Public health relevance
PROJECT NARRATIVE The formation of acinar-to-ductal metaplasia is an early premalignant lesion formed en route to pancreatic ductal adenocarcinoma. This proposal will assess how cell autonomous metabolic changes and heterocellular metabolic interactions with normal healthy cells modulate redox balance and alter early metaplastic transformation. This research proposal will define the role of metabolism in precancerous stages which will inform new diagnostic and therapeutic targets in pancreatic cancer.